South Carolina COBRE in Oxidants, Redox Balance and Stress Signaling

Overall – Abstract
With Phase III COBRE support, the South Carolina Center in Oxidants, Redox Balance, and Stress Signaling
(Redox COBRE) at the Medical University of South Carolina (MUSC) will complete its transition to long-term
sustainability as a nationally competitive multidisciplinary research program in redox pathobiology. During
Phases I and II, our Redox COBRE was successful in its efforts to (i) expand the critical mass of funded
investigators at MUSC studying the causal role of redox pathways and metabolic dysfunction in a wide range of
human pathologies (cancer, cardiovascular and neurodegenerative diseases, diabetes, gastrointestinal
disorders and drug addiction) and (ii) develop advanced scientific core resources offering a broad range of
capabilities for investigating the biologically significant effects of oxidative stress. Our current core membership
comprises 44 senior and junior faculty members that have received more than $51 million in awards since the
program’s inception. To date, the Redox COBRE has mentored a total of 20 target faculty (junior investigators +
pilot project-supported PIs). Of these individuals, 10 have been promoted and 16 have been retained at our
institution. As a group, these faculty members have published more than 250 peer-reviewed papers and secured
56 extramural grant awards (including 31 NIH grants (PI role) of which 16 are R01 awards and 8 are SBIR/STTR-
supported start-ups). The major components of this Phase III proposal are: (1) an Administrative Core providing
organizational, coordinating, fiscal and accountability functions; (2) an Analytical Redox Core delivering
analytical biochemistry services for quantification of redox-sensitive molecule abundance and redox-based
changes in cellular homeostasis; (3) a Proteomics Core that offers state-of-the-art mass spectrometry (MS) and
MS-imaging capabilities; (4) a Cell & Molecular Redox Imaging Core that provides cell and tissue-based
confocal, multiphoton and super-resolution microscopic imaging; and (5) a Pilot Projects Program (PPP) that
fosters research endeavors utilizing Center resources and facilitates collaborations with Redox COBRE
members. Towards our objective of becoming a stand-alone Center of Redox Biology and Signaling (abbreviated
to “Redox Center”), we will build upon our substantial scientific and institutional achievements, to: (Aim 1)
enhance the function and efficiencies of our scientific cores, achieving optimal positioning to serve Center
thematic and translational goals and achieve/ maintain sustainability; (Aim 2) leverage the PPP to grow center
membership and promote the importance of translational redox signaling research in the context of human
disease; (Aim 3) develop the research portfolio and connections between the Redox COBRE and other IDeA
programs to establish ourselves as a national presence coalescing various disciplines and areas of expertise.
Thus, we are seeking to establish a strategic position for long-term success as an emergent, University-
designated Redox Center that will be one of few national resources for investigators to utilize or develop new
technologies, therapeutics and interventions targeting pathological redox pathways.

Public health relevance
Overall – Narrative While oxygen provides the most efficient way to produce energy through oxidative phosphorylation, paradoxically it also produces toxic byproducts. Through adaptation, organisms have evolved numerous redox based stress pathways to counteract this toxicity. In human diseases, these pathways can sometimes malfunction leading to a broad range of human maladies. This COBRE seeks to support faculty and their research in these areas with an agnostic viewpoint on the choice of disease. Our overall goal continues to be to build a sustainable Center that can provide a focal effort to comprehend the integral importance of redox stress signaling in human diseases and the treatment thereof.